High-Throughput Screening for the Discovery of Protein-Binding Fragments

Project Summary
Fragment based drug discovery programs begin with the identification of low molecular
compounds that bind weakly to the protein of interest (POI). POI-binding fragments are
then elaborated and/or linked together to provide lead compounds. Current methods for
screening fragment libraries have low throughput and many require large amounts of the
POI, often in isotopically labeled form. This proposal will establish a novel screening
platform capable of analyzing hundreds of potential fragment-protein interactions in a
single tube. We will create dozens of fluorescently encoded one bead one compound
(OBOC) libraries comprised of hundreds of low molecular weight compounds. They will
be screened against a fluorescently labeled, tetrameric form of the POI. Avidity effects
will stabilize the weak interactions sufficiently to allow the beads to be analyzed by flow
cytometry, identifying those capable of retaining the POI. If necessary, proximity
labeling will be explored to increase the sensitivity of the system. This technology will be
employed to discover novel fragments that engage the VHL E3 Ubiquitin ligase.

Public health relevance
Project Narrative The discovery of low molecular fragments that bind to a protein of interest is an atom-efficient way to initiate a drug development campaign. However, existing methods for fragment discovery are tedious and expensive. This proposal aims to establish a novel screening platform capable of analyzing hundreds of fragment-protein interactions in a single tube using micrograms of target.